INSULIN RESISTANCE EFFECT ON CAPILLARY RECRUITMENT

Recent evidence suggests that insulin increases muscle glucose utilization by increasing blood flow through recruitment of new blood vessels. We hypothesize that insulin's actions as a vasodilator in this fashion is blunted in the obese patient or the patient with Type 2 diabetes mellitus (DM). The initial phase of our study involving 10 health controls has shown a significant increase in glucose uptake and capillary blood volume while receiving a physiologic dose of insulin while total blood flow was not significant increased suggesting a recruitment of blood vessels in the forearm. We will continue our clinical research study in insulin-resistant individuals, 10 obese and 10 Type 2 DM subjects in which we will address the following specific aims: 1) to determine whether insulin resistance in obese normoglycemic humans is accompanied by impaired vascular responses to insulin; and 2) to define whether the insulin resistance present in Type 2 DM includes resistance to insulin's vascular effects in skeletal muscle. Before and after local insulin infusion we will examine total forearm blood flow using plethysmography and Doppler ultrasound. We will use contrast echocardiography, which combines ultrasound imaging with the infusion of albumin coated microbubbles, that will allow measurement of capillary blood volume in vivo for the first time. These techniques will be used in conjunction with an established forearm perfusion method so that the vascular actions of insulin will be compared to the metabolic effect in the same tissue using arterial-venous catheterization. Increasing our understanding of insulin's vascular role will potentially allow for therapeutic interventions designed to normalize insulin resistance in obese and Type 2 DM patients.